Chicago Kidney Urology Hematology network FOR city-Wide reseArch tRaining and career Development (Chicago KUH FORWARD)

Summary of revised scope of work emanating from budgetary reductions:
The number of training slots has been reduced from 10 pre and 10 post-doctoral positions per year to 5 pre and 5 post-doctoral positions per year.
The percent effort for key personnel in leadership positions has been substantially reduced across all leadership positions. For some leadership positions, we have been able to secure modest institutional support to protect effort.
We removed effort for members of Trainee Selection Committee and Diversity Committee. Members of these committees agreed to contribute without effort from the grant.
We removed effort for members of Network and Career Development Cores. Members agreed to contribute without effort from the grant.
5. We removed effort for the following non-key personnel:
a. Evaluation expert
b. Program manager
c. UIC Project manager
These changes to the effort of non-key personnel will be dealt with in the following fashion:
Evaluation of the Overall Program will be scaled down compared to what was described in the original application. Evaluation of the Training Core will remain comprehensive through evaluation services provided for research training programs through a new Core established at Northwestern University and supported through institutional funds.
The effort of the Overall Program Coordinator, Terri Fraterrigo, has remained intact at 100%. A program assistant from the Center of Translational Metabolism and Health at Northwestern University, Anthony Tagliola, will provide support to the Overall Program Coordinator at no cost to the grant. He will be supported through institutional funds.
The UIC program manager, Natalie Meza, will provide support to the Overall Program Coordinator at no cost to the grant. She will be supported through institutional funds.
6. We reduced the amount of funds allocated to the Network Core. While these reductions will curtail activities originally proposed in the application, we are actively working to secure additional funds to support the activities and we will also work with the leaders of the Network Core to design new initiatives that will either be supported through institutional funds or will be organized at minimal cost to the grant.

Public health relevance
Project Narrative Overall The research workforce in areas of Kidney, Urology and Hematology (KUH) needs to be strengthened in order to address pressing scientific questions and find treatments for patients affected by KUH conditions. The current proposal will create an innovative training program that will bring together pre- and postdoctoral trainees across 6 academic institutions across Chicago who will learn together about cross-cutting tools in a way that will allow them to develop a common language, apply the tools into their own research, and form sustained interdisciplinary research interests and collaborations. The results will have important implications for the KUH scientific community and for clinical care of patients with KUH conditions.